Alcohol and Burn Trauma: Multi-organ Inflammatory Responses

Project Abstract/Summary
This R35 MIRA grant application is designed to investigate mechanisms responsible for the exaggerated
effects of alcohol intoxication on multi-organ system responses after burn injury. Of the million people per year
who suffer burn injuries in the U.S., nearly half of the adult patients are intoxicated at the time of injury.
Intoxicated burn patients have increased morbidity and mortality compared to those who had not been
drinking. The lung is the most frequent organ to fail after a remote injury such as cutaneous burn, with 45% of
burn patients showing some form of lung damage even in the absence of inhalation injury. Pneumonia and
acute respiratory distress syndrome (ARDS) are among the major complications seen in intoxicated burn
patients. Little is known about the mechanism by which alcohol intoxication upregulates the post-burn systemic
inflammatory responses that lead to excessive pulmonary inflammation and increased susceptibility to lung
infection. Recently, we reported that the post-burn pulmonary inflammatory response is exacerbated in
intoxicated subjects because of a breach in the integrity of the intestinal epithelial barrier secondary to burn.
This, along with dysbiosis of the fecal microbiome, could be critically involved in the systemic inflammation
seen after burn injury. We and others have shown that burn trauma and alcohol intoxication independently
cause these intestinal changes and that, after the “two hit” insult of alcohol and burn injury, these responses
are amplified, which could result in a more dramatic shift in the microbiome and a greater release of bacterial
products and endotoxins into the circulation, triggering systemic inflammation and damage to distant organs
like the lung. To date, we know very little about how and when the intestine recovers from remote injury, such
as a cutaneous scald burn, and even less about how factors including alcohol intoxication prior to injury alter
that process. In this research program, we will use our clinically-relevant murine model of alcohol intoxication
and burn injury along with burn patients, some of whom will have consumed alcohol prior to sustaining their
injuries, to address the following questions: 1) What are the effects of alcohol intoxication and burn injury on
the gut, specifically, the integrity of the intestinal epithelial barrier and the fecal microbiome, and how long do
they last? 2) Can intestinal epithelial cell barrier dysfunction be accurately monitored by measuring plasma
biomarkers of intestinal epithelial cell damage, microbial translocation and inflammation, rather than by more
invasive tests? 3) Are there gut-directed therapies that can restore the intestinal barrier and microbial
homeostasis, which, by virtue of reducing systemic inflammation, will improve the function of distal organs,
such as the lung? Taken together, these studies will expand the knowledge of how alcohol exposure alters the
gut in the context of remote injury such as burns and may lead to the development of novel therapies for the
treatment of patients with burns and other forms of trauma.

Public health relevance
Project Narrative Damaging more than just the skin, burn injury can lead to infection and multi-organ failure, often stemming from gut microbiome dysbiosis and a breach in the intestinal barrier, allowing translocation of bacteria and bacterial products into the circulation and triggering excessive inflammation in the lung and other distal organs. Nearly half of all adult burn patients consumed alcohol prior to sustaining their injury and, since alcohol intoxication and burn injury independently effect the microbiome and gut permeability, subjects with the combined insult of alcohol and injury have heightened inflammatory responses and worse outcomes. This MIRA grant will allow my laboratory to continue to define mechanisms responsible for gut dysfunction after injury and to monitor/intervene to accelerate the recovery of this organ using our clinically relevant model of alcohol intoxication and burn injury and in burn patients who are at risk of developing failure of critical organs like the lung.